Uncovering The Mechanogenomic Basis For Cardiac Plasticity

PROJECT SUMMARY / ABSTRACT
Inherited mutations in sarcomeric genes, which decrease cardiac myocyte tension generation, are principal
drivers of dilated cardiomyopathy (DCM)– the leading cause of heart failure. Progress towards developing
precision therapeutics for and defining the underlying determinants of DCM has been entirely cardiac myocyte
centric with negligible attention directed towards fibroblasts despite their role in regulating the best predictor of
DCM severity, cardiac fibrosis. Our recent findings in a mouse model of inherited DCM demonstrated that prior
to the onset of fibrosis and dilated myocyte remodeling both the myocardium and extracellular matrix (ECM)
stiffen from enhanced collagen fiber alignment and expansion of the cardiac fibroblast population, which was
reversed by blocking cardiac fibroblast function with targeted genetic silencing of p38. This cardiac fibroblast-
targeted intervention unexpectedly improved the primary cardiac myocyte defects in contractile function and
reversed ECM and dilated myocardial remodeling. Together these findings challenge the long-standing paradigm
that ECM remodeling is a secondary complication to inherited defects in myocyte contractile function and instead
demonstrate cardiac fibroblasts play an unequivocal role in DCM outcomes. As an extension of this work we
propose the overarching hypothesis that atypical p38-mediated fibroblast adaptations to DCM-linked sarcomere
mutations are irreversible with myocyte-centric approaches, owing to the disproportionate expansion of
sensitized and hyperresponsive Periostin+ fibroblasts during postnatal development that when left functionally
enabled by myocyte-targeted therapies leave inherited DCM hearts vulnerable to heightened fibrosis. This
hypothesis will be tested with the following aims: [Aim 1] Examine the developmental & molecular basis for
adaptive cardiac fibroblast expansion in an inherited DCM mouse model; [Aim 2] Examine the effectiveness of
myocyte versus fibroblast-targeted genetic interventions at various stages of DCM disease progression; and
[Aim 3] Examine the generalizability of p38-dependent cardiac fibroblast response to inherited & acquired DCM.
Outcomes from this work will start to resolve unknown fibroblast-based mechanisms that link primary myocyte
defects with the DCM disease process and identify whether therapeutic interventions for DCM may require
fibroblast-specific strategies to be effective.

Public health relevance
PROJECT NARRATIVE Newly identified findings that disabling cardiac fibroblast by p38 deficiency corrects the dilated cardiomyopathy (DCM) phenotype in mice expressing a sarcomeric variant demonstrates fibroblasts play an unequivocal role in early-stage DCM pathogenesis. In the DCM setting cardiac fibroblasts adaptively responded to the sarcomeric variant by proliferating but failed to undergo canonical activated state transitions, which resulted in myocardial anisotropy and stiffness albeit without conventional fibrosis. Understanding the underlying determinants of adaptive cardiac fibroblast responses, what mechanical property of the heart the fibroblast response is trying to correct, and whether therapies for inherited DCM will need to target fibroblast-dependent processes is vital to overcoming current limitations with standard-of-care and first-in-class muscle cell-specific interventions.